Decoding the Molecular Choreography of Diverse Vesicle Release Mechanisms

Project Summary
The fusion of large dense-core vesicles (LDCVs) with the plasma membrane is essential for the secretion of
peptides, hormones, and growth factors in neurons and endocrine cells. This tightly regulated process governs
critical physiological functions, including metabolic homeostasis, immune responses, synaptic transmission,
appetite regulation, circadian rhythms, and stress management. Disruptions in vesicle fusion are linked to
neurological disorders, diabetes, immune dysfunction, eating disorders, depression, addiction, and cancer.
Despite its significance, the molecular mechanisms of LDCV release remain poorly understood. The central
hypothesis of this proposal is that distinct v-SNARE-containing vesicle populations form unique SNARE
configurations, driving different modes of release and fusion pore kinetics. This innovative hypothesis challenges
the prevailing view of a single core protein machinery governing vesicle fusion and suggests multiple vesicle
types with varying calcium sensitivities. The unresolved debate between full fusion and the kiss-and-run (KR)
mechanism has persisted due to technological limitations and the transient nature of these events. Our SLIM
technology overcomes these barriers, enabling real-time tracking of vesicle fates and providing insights into the
mechanisms behind KR and full fusion. This project will explore vesicle heterogeneity, synchronous and
asynchronous exocytosis, and fusion pore kinetics, providing new insights into vesicle release mechanisms.
Utilizing advanced technologies and cellular assays, this MIRA research program will address how vesicle
heterogeneity dictates different fusion kinetics in LDCVs (Theme 1) and investigate the role of phospholipase in
calcium signaling and lipid dynamics at fusion sites, while developing next-generation suspended lipid membrane
platforms based on the design principles of organic neuromorphic devices for observing ultrafast fusion kinetics
(Theme 2). The technologies we develop in this proposal will benefit the fields of membrane biophysics, cell
biology, and single-molecule imaging. Ultimately, uncovering the principles of LDCV release will link intracellular
and intercellular signaling with implications for treating metabolic diseases, psychological disorders, and
neurodegenerative diseases. The results will impact numerous scientific fields, including cancer, cardiology,
metabolism, and neuroscience.

Public health relevance
Project Narrative This MIRA proposal seeks to uncover the molecular mechanisms governing the fusion of large dense-core vesicles (LDCVs), which are essential for the secretion of hormones, peptides, and growth factors that regulate critical physiological processes. By investigating how disruptions in vesicle fusion contribute to diseases such as diabetes, neurological disorders, and immune dysfunction, this research will provide transformative insights. The development of innovative technologies, including the SLIM platform, will significantly advance the fields of membrane biophysics and single-molecule studies.